Investigating the anti-tumor roles of tumor-draining lymph nodes in renal cell carcinoma

Project Summary/Abstract
While cancer immunotherapy has transformed the treatment of solid tumors, most patients do not receive durable
clinical benefit. CD8+ T cells are critical mediators of anti-tumor immunity, targeting and killing cancer cells, with
immune checkpoint blockade (ICB) therapies designed to amplify their tumor-specific cytotoxic functions. Under
chronic antigen stimulation in the tumor microenvironment (TME), exhausted CD8+ T cells progressively
differentiate from progenitor exhausted (Tpex) cells with self-renewal capacity, to intermediate exhausted (Tex-int)
cells with peak cytotoxicity, and finally to terminally exhausted (Ttex) cells with diminished proliferation and effector
functions. In mouse lung cancer models, the tdLN was identified as a reservoir of Tpex that differentiate into tumor-
infiltrating lymphocytes (TILs), sustaining anti-tumor immune responses over time. Additionally, Tpex are the
primary target of ICB, expanding and differentiating into Tex-int that mediate effective anti-tumor immunity.
However, given the limited efficacy of ICB in most patients, it remains unclear whether these findings are
generalizable across cancer types (or are model-specific), and whether this biology translates to human cancers.
To investigate this, our lab has extensively characterized TILs in patients with clear cell renal cell carcinoma
(RCC) through single-cell RNA sequencing (scRNA-seq), establishing that tumor-specific CD8+ T cells are
overwhelmingly found within exhausted T cell compartments. Further, scRNA-seq of human RCC TILs found a
higher baseline of Tpex and a greater shift from Tpex to Ttex in patients responding to anti-PD-1-based ICB
compared to non-responders, suggesting Tpex are critical for ICB response in RCC. However, the tumor-
specificity, phenotypic states, tissue compartmentalization, and effector functions of CD8+ T cells in solid tumors
are not fully understood. In Specific Aim 1, I will leverage collaborations with surgeons, pathologists, and clinical
oncologists to identify tumor-specific CD8+ T cells in matched tumor and tdLN specimens from RCC patients,
characterizing their lineage relationship, phenotype, and effector functions. This will define the role of the
periphery and T cell subsets in anti-tumor responses in human solid tumors. In Specific Aim 2, I will utilize a
dominant antigen-engineered syngeneic mouse model of RCC to track tdLN-derived tumor-specific CD8+ T cell
migration, investigating whether tdLN anti-tumor responses are consistent across immunotherapy-treated
cancers and providing critical insights into T cell migration in RCC. Achievement of these aims will uncover the
role of the tdLN and exhausted CD8+ T cell populations in sustaining anti-tumor immunity, assess their relevance
to RCC and other solid tumors, and identify key T cell subsets as candidates for adoptive cell therapy. The
collaborative environment at Yale University, paired with state-of-the-art resources and facilities, along with the
dedicated mentorship of Dr. Braun and Dr. Bosenberg, provides an ideal setting to complete this research and
develop into an independent investigator.

Public health relevance
Project Narrative Cytotoxic CD8+ T cells play critical roles in anti-tumor immunity, but they become exhausted in the solid tumor microenvironment and lose the ability to kill cancer cells. Studies in mice demonstrate that stem-like CD8+ T cells in the tumor-draining lymph nodes (tdLNs) play a key role in sustaining anti-tumor immunity, but how this translates to human solid tumors remains unclear. This project aims to leverage complementary human and mouse models of renal cell carcinoma to investigate how CD8+ T cell subsets and tdLNs drive anti-tumor immunity, advancing our understanding of these mechanisms and informing the development of adoptive cell therapies.